Supplement Year 2: USC FaceBase III Craniofacial Development and Dysmorpholoy Data Management and Integration Hub

PROJECT SUMMARY
The major goal of the FaceBase Consortium is to advance research by creating
comprehensive datasets of craniofacial development and dysmorphologies, and to
disseminate these datasets to the wider craniofacial research community. The
FaceBase 3 Data Management and Integration Hub builds on the existing and
successful scientific and technical team that has lead the development, deployment,
operation and community engagement of the FaceBase 2 data hub. Looking
forward to the future impact of the FaceBase Consortium, we face major challenges
that include: (1) how to annotate large datasets to empower the biomedical research
community; (2) how to improve data integration and facilitate data search and
retrieval from the hub; (3) how to use the data from FaceBase to design studies and
otherwise inform our future research; and (4) how to translate our knowledge from
animal model studies to improve human craniofacial health. Importantly, the projects
we propose here are designed to address these issues as we develop anatomy-
based comprehensive data search and display, incorporate additional datasets from
the community, and promote the usage of FaceBase data. In pursuit of these goals,
we propose the following three Specific Aims: Specific Aim 1: Create a FAIR data
repository and resource hub for the craniofacial research community. Specific Aim
2: Promote and enable data contributions to FaceBase by NIDCR-supported
researchers. Specific Aim 3: Foster a community of active FaceBase users through
outreach activities and dissemination of new features and available datasets. We
will create educational materials and provide training opportunities for the next
generation of craniofacial researchers. Ultimately, our proposed projects will not
only contribute to our comprehensive understanding of the molecular regulatory
mechanisms of craniofacial development but will also demonstrate how others can
use the datasets from the FaceBase Hub to develop innovative approaches to
improve human health.

Public health relevance
Contact PD/PI: Kesselman, Carl PROJECT NARRATIVE The major goal of the FaceBase Consortium is to advance research by creating comprehensive datasets of craniofacial development and dysmorphologies, and to disseminate these datasets to the wider craniofacial research community. We propose to develop anatomy-based comprehensive data search and display, incorporate additional datasets from the community, and promote the usage of FaceBase data. Ultimately, our proposed projects will contribute to our understanding of craniofacial development and demonstrate how others can use the datasets from FaceBase to develop innovative approaches to improve human health. Project Narrative Page 7